ANTIGENIC STRUCTURE OF PURIFIED HOUSE DUST MITE ALLERGEN

House dust mites (Dermatophagoides) are an important cause of allergic diseases such as perennial rhinitis, asthma and atopic dermatitis and the two principal species, D. pteronyssinus and D. farinae have been found in homes in many parts of the United States. The aims of this project are to determine the primary structures and the antigenic relationships between the two major groups of dust mite allergens: the 24kd Group I allergens (der p I, Der f I, and Der m I) and the 15kd Group II allergens (Der p II and Der f II). The amino acid sequences of these allergens will be determined using the combined approaches of peptide sequencing (Edman degradation and tandem mass spectrometry) and cDNA cloning in Lambda gt 10. Structural homology between each allergen and other proteins of known amino acid sequence will be compared. Binding of murine monoclonal antibodies and human IgG and IgE antibodies to both allergen groups will be compared by antigen binding radioimmunoassays. Epitope mapping studies will be carried out by comparing antibody binding to denatured allergens, chemically modified allergens and peptide fragments. The aim will be to determine the repertoire of B cell epitopes, whether they are sequential or topographic and which amino acid residues provide the contact points for antibody binding. Murine antibody responses to Group I allergens will be compared in several inbred strains using different immunization regimes to investigate whether modes of immunization which affect isotype expression also influence epitope specificity. Human T cell responses to the Group I and II allergens will be compared n in vitro cell culture systems using peripheral blood T cells from mite allergic patients. Synthetic peptides will be used to stimulate T cell clones and to identify T cell epitopes. The role of antigen presenting cells in processing allergens prior to presentation to T cells will also be investigated. This proposal provides a systematic approach to studying the molecular and antigenic structure of major dust mite allergens. These studies should result in greater understanding of factors which influence both humoral and cellular immune responses to mite allergens. They should also provide further knowledge as to why these allergens are such a common cause of rhinitis, asthma and atopic dermatitis.